Inner Strength and Influencing Factors in Persons Newly Diagnosed with Mild Cognitive Impairment and their Family Care Partners

Project Summary/Abstract:
The purpose of this individual National Research Service Award (NRSA) application is to provide the
applicant with essential research training to become an independent investigator focusing on strengths-based
interventions for people living with Mild Cognitive Impairment (MCI), specifically those that improve quality of
life by enhancing inner strength. This NRSA will ensure that the applicant achieves competence in establishing
a conceptual understanding of inner strength, develops foundational skills to commence a program of ethical
and rigorous independent research with the vulnerable population of persons with MCI and their family care
partners, and gains professional development skills to advance in a rigorous academic setting. This training will
occur in a resource rich environment with support from a world-renowned advising team ideally suited to the
applicant’s topic and training plan. From her clinical experience as a nurse, the applicant has first-hand
knowledge of the importance of and need to incorporate a person’s strengths into their plan of care.
One in five people age 60 and older are living with MCI. The vast majority of interventions for persons
with MCI focus on minimizing deficits rather than augmenting strengths to improve quality of life. This gap is
due to under-characterization of strengths of persons with MCI in the literature. One opportunity to fill this gap
is to describe inner strength from the perspective of the person living with MCI. Inner strength is defined as
one’s internal process of moving positively through challenging circumstances and is associated with improved
quality of life. Inner strength is well described in adults with serious illnesses like cancer and heart disease but
is not well characterized in MCI. This study proposes to fill this gap in knowledge through the following aims: 1)
To describe the experience of inner strength in persons newly diagnosed with MCI, 2) To explore how family
care partners impact the experience of inner strength for persons newly diagnosed with MCI, 3) To identify
external factors that influence inner strength for persons newly diagnosed with MCI. This study will use realist,
qualitative methodology to focus on the experience of the individual. This study proposes to use thematic
analysis that employs voice-centered methods of analysis applied to interviews of persons with MCI and their
family care partners. This study has the potential to provide new knowledge about inner strength in persons
with MCI and elucidate influencing factors and the role of family care partners. The proposed study aligns with
NINR’s strategic plan to improve quality of life for individuals with chronic conditions, like MCI, as this work has
the potential to unlock opportunities to enhance inner strength and thereby quality of life. By laying a strong
foundational knowledge of inner strength, we can better design interventions that are based in what matters to
persons with MCI and their care partners. Future implementation research has the potential to have a
significant impact for quality of life.

Public health relevance
Project Narrative The long-term goal of this research program is to inform strengths-based interventions for people with Mild Cognitive Impairment (MCI) that focus on enhancing inner strength and supporting quality of life. This proposal lays the foundation for future work by describing the experience of inner strength from the perspective of people newly diagnosed with MCI and exploring factors that influence that experience at the crucial point of diagnosis. As desired by individuals with MCI, their care partners, and the NIH, this work will help to provide a more balanced view of life with MCI on which to base future interventions by focusing on strengths.